THE GENETICS AND MULTI-OMICS SPECIMENS CORE (GMSC)

ABSTRACT FOR GMSC
Aging populations worldwide, particularly in developed countries, face an increasing burden of
neurodegenerative diseases. Genetic studies have greatly contributed to our understanding of these complex
diseases. Now it is clear that studies beyond genetics, such as transcriptomics, proteomics, or epigenomics are
needed to fully understand the biology of neurodegeneration and healthy aging, to identify novel biomarkers and
identify novel targets. The goal of the Genomics and Multi-omics Specimens core (GMSC) is to obtain, bank and
quality control (QC) biospecimens (DNA, RNA and plasma) from AABC participants. The core will generate
GWAS, APOE and polygenic risk scores for all participants that will be used by other AABC Projects. We will
also generate longitudinal multi-omic (classic blood analytes, anti-Müllerian hormone (AMH), Alzheimer disease
(AD) biomarkers, and neuroinflammation proteomics) blood data that will be used for Projects 1-4 to determine
biomarker positivity for AD, allosteric load, inflammation, lifestyle behaviors, and the menopausal transition that
are instrumental for those projects.

Public health relevance
NARRATIVE FOR GMSC We will provide material for sending blood samples from recruiting sites to Washington University School of Medicine (WUSM). We will process blood samples and store DNA, RNA, buffy coat and plasma. We will distribute samples as requested by the AABC Executive Committee. We will generate GWAS data and generate polygenic risk scores that will be shared with the Projects to identify genes associated with dementia, healthy aging and imaging phenotypes. Blood proteomic data will be also generated in a longitudinal manner to identify changes in well-known Alzheimer’s biomarkers (Aβ, p-tau, NfL) metabolic and inflammatory biomarkers associated with aging and dementia.